WIFI INSTRUMENT DESIGN AND VALIDATION STUDIES

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. These studies are meant to build initial prototpe instrumentation for WiFI platform. This platform will combine reflectance, fluorescence, and speckle measurements. The initial validation studies will include a series of phantom measurements to validate instruments and initial attempts at model development